Stepped care to optimize PrEP effectiveness in pregnant and postpartum women (SCOPE-PP) in South Africa

PROJECT SUMMARY: HIV incidence doubles during pregnancy and postpartum period compared with non-
pregnant women, underscoring the urgent need for prevention interventions tailored to high-risk
pregnant and breastfeeding women. Incident maternal HIV infections lead to an estimated one-third of all
infant HIV infections. South Africa expects over 76,000 infant HIV cases in the next decade; one-third of those
can be prevented by eliminating maternal HIV acquisition. Pre-exposure prophylaxis (PrEP) in pregnancy and
breastfeeding is safe and effective at preventing HIV. However, PrEP use remains low in pregnancy, and drops
precipitously in the postpartum period. Our team is made up of experts in epidemiology, behavioral science,
health economics and HIV prevention in pregnant women from University of California Los Angeles and the
University of Cape Town. Together we have implemented one of the first studies to integrate PrEP into
antenatal care in South Africa (“PrEP-PP”; R01MH116771). We propose to test a novel strategy to optimize
PrEP in pregnant and postpartum women in South Africa. Our randomized control trial (RCT) is designed
to address key barriers to maternal PrEP use and evaluate cost-effectiveness to inform national policy.
This trial builds on our earlier work demonstrating the acceptability, feasibility, safety and potential efficacy of a
package of interventions including PrEP, HIV self-testing (HIVST) for the participant and her partner(s), and
enhanced adherence counseling (with bio-feedback on adherence) combined with home PrEP delivery for
women who want to take PrEP but have difficulties adhering. We developed and piloted a novel intervention
entitled, Stepped Care to Optimize PrEP Effectiveness in Pregnant and Postpartum women (SCOPE-PP)
that addresses barriers to taking daily PrEP by reducing clinic visit frequency and empowering women to
adhere to PrEP. We will evaluate SCOPE-PP in a pragmatic RCT of pregnant and postpartum women at risk of
HIV acquisition. We will enroll 500 pregnant women in antenatal care and follow them through 12m
postpartum. Women in the intervention will be offered: HIVST for participants & partners, rapid PrEP collection
with enhanced adherence counseling. Women with poor PrEP adherence will be offered a differentiated care
model of home PrEP delivery to de-link PrEP from clinical visits. The primary outcome is PrEP continuation
and adherence in postpartum women, measured through drug levels of tenofovir diphosphate. We aim to: 1)
Evaluate the efficacy of the SCOPE-PP intervention on PrEP adherence in pregnant and postpartum women
in a RCT; 2) Assess the acceptability and feasibility of integrating SCOPE-PP into ante- and postnatal
care using a consolidated framework for implementation research; and 3) Estimate the incremental cost
effectiveness of SCOPE-PP vs. standard of care per HIV infection and disability-adjusted life-year averted.
This research is critical to inform maternal PrEP interventions to eliminate HIV acquisition and transmission in
South Africa and beyond.

Public health relevance
PROJECT NARRATIVE To reach HIV-uninfected pregnant and breastfeeding women in South Africa, who are at very high risk of HIV acquisition, we will test a new and innovative package of interventions: 1) pre-exposure prophylaxis (PrEP), which is both safe and effective for preventing HIV in pregnant and breastfeeding mothers; 2) HIV self-testing for the participant and her partner(s); and 3) enhanced adherence counseling combined with home-based PrEP delivery for women who have difficulties with regular PrEP use. Our study will be among the first ever to evaluate the efficacy and cost-effectiveness of a PrEP intervention among pregnant and postpartum women and will play a key role in informing maternal PrEP interventions to eliminate HIV acquisition and transmission to partners and their infants.